Conference grant application to support the American Psychosomatic Society's 73rd Annual Scientific Meeting

? DESCRIPTION (provided by applicant): Providing strong support and guidance to promising pre- and post-doctoral students is crucial for the advancement of all fields of science. The overall goal of this competing renewal of R13 HL074923 is to provide travel support for trainees to attend and actively take part in the 73rd Annual Scientific Meeting of the American Psychosomatic Society (APS) in Savannah, Georgia (March 18 - 21, 2015). The essential mission of the APS is to promote and advance the scientific understanding of the interrelationships among biological, psychological, social and behavioral factors in human health and disease, and the integration of the fields of science that separately examine each, and to foster the application of this understanding in education and improved health care. This mission is instantiated in the selection of the theme for the 2015 meeting, From Cells to Community and Back, which will highlight empirical research, applied methodology, and clinical applications along the translational continuum. For greater than 7 decades, the annual APS meeting has provided an outstanding forum for trainees and established investigators and clinicians working within a wide range of disciplines and specialty areas to exchange new ideas and research strategies that ultimately facilitate and improve the quality of research and its translation into clinical practice and public policy. The annual APS meeting is attended by over 500 researchers and clinicians from around the world. For the past 9 years, NHLBI has been the sponsoring institute for this award given that the annual scientific meeting of the American Psychosomatic Society is the only scientific conference focused on the bio-psycho- social determinants and consequences of cardiovascular disease. Planned programming for the 2015 meeting includes a keynote address by Dr. Daniel J. Buysse, an invited symposium on the Jackson Heart Study updates, and a CDC symposium on the causes and consequences of health disparities. Regular presenters in Cardiovascular Behavioral Medicine include luminaries such as Drs. Neil Schneiderman, Michael Irwin, Redford Williams, Margaret Chesney, Julian Thayer, Andrew Steptoe, Karen Matthews, Stephen Manuck, and Richard Lane. Increasingly, this conference has also highlighted relationships among sleep and health with accepted abstracts focused on sleep increasing by 80% from 2003 to 2013. Support is also requested from other institutes (e.g., NCI, NCCAM) given the diversity of disciplines and specialties represented at this meeting. In this competing renewal, we propose to provide support for up to 10 Young Scholar Awards and 5 Minority Initiative Travel Awards. The Young Scholars Award Program will provide travel awards to competitively- selected trainees who submit a first-author abstract to present a paper or poster and who are judged to show outstanding potential for a career in psychosomatic and behavioral medicine. The APS Minority Initiative Travel Award will provide support for promising trainees from racial/ethnic or other underrepresented groups to attend the annual meeting. The process of identifying and selecting APS Minority Initiative Travel Award recipients will differ, as this award seeks to extend trainee award opportunities to individuals who are not yet stakeholders in the process. The meeting's location in Georgia will capitalize on regional expertise in health disparities, with an emphasis on new data related to the causes and consequences of disparities in the stroke belt.

Public health relevance
PUBLIC HEALTH RELEVANCE: Providing strong support and guidance to promising pre- and post-doctoral students is crucial for the advancement of all fields of science. The competing renewal of R13 HL074923 proposes to provide travel support for up to 15 trainees to attend the 73rd Annual Scientific Meeting of the American Psychosomatic Society (APS). (End of Abstract)